Harnessing culturally-appropriate, technology-assisted methods to advance suicide prevention among youth in Colombian school settings

Harnessing culturally-appropriate, technology-assisted methods to advance suicide prevention among
youth in Colombian school settings
PROJECT SUMMARY
This study will investigate a multi-level approach that leverages innovative, culturally appropriate
technology-assisted methods to reduce suicidal thoughts and behaviors (SIB) and promote mental health
among Colombian youth: (a) digital platform for youth; (b) digital platform for teachers; and (c) hybrid mental
health training diploma program for teachers. This approach will leverage school settings and technology-
assisted methods to reduce gaps in access to evidence-based suicide prevention interventions in a low- and
middle- income country. The open-access digital platform was developed through a co-design process with
Colombian youth to ensure that it was culturally appropriate, engaging, and easy to use. Key features of the
digital platform include mental health self-help tools, a customizable safety plan, links to online counseling
services, and gamification elements. The digital platform’s teacher interface will incorporate psychoeducation,
brief suicide-risk screening and decision support tools to enhance teacher capacity to assess risk for suicide
and refer youth to the appropriate level of services. The Exploration, Preparation, Implementation, Sustainment
(EPIS) framework, a broad multilevel, context-sensitive implementation science model, will guide the study. A
hybrid-type 1 implementation-effectiveness stepped wedge pilot trial design will allow for evaluation of the
digital platform and hybrid mental health teacher training program implemented within secondary schools in
Bogota, Colombia. Study aims are to:
Aim 1. Conduct an initial needs assessment with key stakeholders (youth, teachers, caregivers, school
administrators) to identify implementation barriers and facilitators. A mixed methods evaluation will guide co-
creation of a tailored implementation blueprint prior to the implementation phase. User-centered design
methods will be used to refine the digital platform and incorporate end-user feedback into the final prototype.
Aim 2. Evaluate the feasibility, acceptability, usability and preliminary effects of the digital platform
implemented within school settings (N=3) in reducing SIB and improving mood (e.g., anxiety/depression)
among Colombian youth aged 14-19 (N=150) via a mixed methods approach. Safety planning skills acquisition
(youth-level) and linkages to mental health services (service-level) will be assessed as mechanisms of change.
Aim 3. Implement a multi-disciplinary capacity building model to strengthen behavioral health and
implementation science research, healthcare delivery capacity, and mental health policy. In partnership with
Pontificia Javeriana University, experts in suicide prevention, data science, and implementation science will be
engaged to build in-country research capacity at the individual and institutional level. Engaging with the Bogota
Mayor’s Office and community advisors will help to better disseminate research findings to key stakeholders.

Public health relevance
PROJECT NARRATIVE This study aligns with NIMH strategic priorities and will strengthen the public health impact of NIMH- supported research by leveraging low-cost technology to improve the accessibility, efficiency, and scalability of evidence-based suicide prevention interventions for youth in Colombia. Study aims will investigate the innovative use of technology-assisted methods to reduce suicide risk and promote mental health among youth within the education sector. Study results have the potential to galvanize political will and improve adoption and sustainability of evidence-based, suicide prevention interventions within the education sector as well as in other alternative delivery settings able to reach vulnerable youth in LMICs and other low resource regions.